Association between early Candida infection (oral thrush) and severe early childhood caries

PROJECT SUMMARY
The proposed K23 career development award in clinical and translational research will form a foundation for Dr.
Yuan Liu to become an independent clinician-scientist, with expertise on severe early childhood caries (S-ECC).
The K23 training objectives progress in a sequential fashion and will support her development of key expertise
in 3 areas: 1) developing advanced skills in designing and conducting clinical studies; 2) acquiring advanced
knowledge and methods in fungal biology and microbiome; 3) improving scientific communication, grant writing
skills and networking. The candidate will acquire experience in directing longitudinal study and essential training
by making the use of the extensive resources at the University of Pennsylvania and capitalizing on an
interdisciplinary mentoring committee with broad, complementary expertise in clinical research, epidemiology,
bioengineering, microbiome, and bioinformatics. S-ECC is a major public health problem characterized by
dysbiotic oral microbial burden leading to a persistent and virulent biofilm on the teeth of toddlers that causes
rampant tooth decay. This process not only destroys the dentition but can also have a negative impact on the
general health, such as complicated systemic infections, and the well-being of young children. Emerging clinical
evidence has spotlighted the potential role of Candida albicans in S-ECC. Furthermore, our retrospective study
using electronic health records (EHR) from six major children’s hospitals revealed that, oral thrush
(oropharyngeal candidiasis or OPC) detection in toddlers less than 12 months of age was strongly associated
with the development of dental caries soon after, particularly between 13 and 36 months. However, only cross-
sectional human studies have been performed thus far. Longitudinal studies are warranted to better assess the
causal association between OPC and S-ECC in toddlers. In parallel, further studies are needed to determine the
fungal role in caries and if Candida colonization in oral cavity could be a reliable clinical marker for risk of S-ECC.
To address this, the proposed research will be focused on conducting a 2-year prospective longitudinal study to
investigate the association between early OPC and the progression of S-ECC, and the impact of Candida
colonization on the functional plaque microbiome and biofilm virulence. Dr. Liu will investigate 3 specific aims:
(1) examine the association between early OPC and S-ECC development in a cohort of infants; (2) evaluate the
influence of OPC and Candida colonization on the plaque microbiome in infants; (3) study the role of Candida
on biofilm cariogenic properties. Results from this clinical and translational effort will further elucidate the causal
link between OPC and S-ECC, and enhance the understanding of fungal contributions to the etiopathogenesis
of S-ECC. Collectively, these results will provide future opportunities for mechanistic clinical studies and
developing targeted strategies for preventing S-ECC. This K23 award will provide Dr. Liu with new knowledge in
the areas essential to her career goals as a clinician-scientist, implement the proposed research plan and build
an independent research program with the goal of receiving an R01 prior to the end of the K23 award.

Public health relevance
PROJECT NARRATIVE Early childhood caries (ECC) remains the most common chronic childhood disease worldwide and causes a major impact on children, families, and healthcare systems, especially in low- and middle-income countries and underserved populations. Candida is frequently detected in the oral cavity of toddlers with severe ECC (S-ECC) and its presence is implicated with an elevated risk for S-ECC, but its role on the etiopathogenesis of the disease remains unclear. This study aims at elucidating whether early Candida infection in children during the first year of life is associated with S-ECC onset and severity in a longitudinal study.